Biospecimen & Clinical Database Core

PROJECT SUMMARY/ABSTRACT
This Biospecimens, Pathology, and Clinical Database Core will not only furnish essential services for the
individual projects by managing patient data, safety, and samples, but it will provide a link between clinical data
and research outcomes and interface with the Biostatistics and Bioinformatics Core to allow for formal
interactions between existing datasets to develop relational networks. It will accomplish its goals by integrating
with and building upon existing, successful infrastructure housed at the Mayo Clinic, making the Core an
efficient, integral component of this SPORE.
The significant patient referral base and clinical practice at the Mayo Clinic (>10,000 patient visits annually with
multiple myeloma and related conditions) will allow substantial patient recruitment to the clinical trials and
translational studies in this Mayo SPORE in multiple myeloma. The already extant 12,000+ bone marrow
samples in our Biospecimens Core make SPORE and DRP projects possible. The on-going initiative of
collecting data and research specimens from additional myeloma patients will feed into all SPORE projects and
make Development Research and Career Development Award Programs possible. The Aims of the Core are:
1. to provide support for collection, transport, processing and storage of samples;
2. to supply the data system infrastructure to track all SPORE patients and samples;
3. to provide coordination and oversight of distribution of samples to SPORE investigators; and
4. to serve as a resource of expertise, collaborative support and service for full projects as well as Career
Enhancement and Developmental Research Awardee research.
This Core provides a mechanism of consistent and compatible data handling, thereby facilitating management
of collected data and integration with data from existing Mayo resources. Areas of data support include
database development, data form development and processing, quality control, data collection and entry, and
data archiving. This Core is unique not only in its scope and potential, but also in that it will be built on existing
(but currently unfunded) tissue banking facilities and processes at the Mayo Clinic in Rochester and in Arizona,
guaranteeing successful performance. Finally, the Core will interface with the clinical research components of
other SPORE grantees and cancer centers to facilitate multi-institutional clinical research arising out of national
myeloma research efforts.

Public health relevance
PROJECT NARRATIVE Effective myeloma research requires blood and tumor tissue connected to patient records for translational research. The Biospecimens, Pathology & Clinical Database Core coordinates all specimen-related research for projects in the Myeloma SPORE. This Core has developed new innovations in natural language processing that will enable investigators to expand myeloma research in the next funding period.